Episodic Memories of 9/11 terror attack and Mental Health: Natural Language Processing of Adolescent and Adult Survivors' narratives (EMLAS study)

Abstract
The mental health effects of the World Trade Center (WTC) attacks on adults first responders and survivors
are well-documented, with elevated rates of PTSD, depression, and anxiety. However, less research has
focused on how the 9/11 attacks impacted children and adolescents who were exposed to the trauma. While
PTSD was less common in these younger populations, studies suggest they experienced heightened anxiety,
particularly separation anxiety, and other emotional disturbances. Furthermore, the onset of symptoms in this
age group often emerged later, highlighting the need to explore the delayed effects of trauma across
developmental stages. Adolescence is a critical period of emotional, social, and cognitive development, and
trauma during this time can disrupt these processes, leading to long-term impairments in executive function,
emotional regulation, and memory. Therefore, adolescents may be more vulnerable to the enduring effects of
trauma, which can manifest in adulthood through poor coping mechanisms, emotional blunting, identity
challenges and mental health disorders. Given that the 9/11 attacks occurred nearly 25 years ago, we will use
memory recollection as means to understand current mental health status of those who were adolescents at
the time of 9/11 attack. Our approach is based on the understanding that traumatic memories are often
encoded differently from non-traumatic ones due to the brain’s heightened stress response, making them
difficult to forget and more emotionally charged. These memories play a critical role in shaping long-term
mental health, contributing to conditions such as PTSD, depression, and anxiety. Additionally,
autobiographical memory, particularly in trauma, can be fragmented, emotionally intense, and less
contextually anchored in younger individuals. The proposed research aims to use Natural Language
Processing (NLP) to analyze the spoken narratives of 9/11 survivors, comparing those who were adolescents
at the time of the attacks to adults. NLP has proven to be a powerful tool in mental health research, identifying
linguistic and emotional markers indicative of psychological distress. By comparing 9/11 narratives with those
related to more recent traumas, such as the COVID-19 pandemic, when all participants were adults, we can
assess how developmental stages at the time of trauma influence memory recall and how is related to current
mental health. Ultimately, this research seeks to identify distinct narrative markers that correlate with mental
health outcomes, contributing to the understanding of how trauma experienced at different developmental
stages impacts long-term psychological well-being. This approach has the potential to inform future
interventions, enabling more personalized targeted treatment for trauma survivors to improve mental health
outcomes.

Public health relevance
While the long-term mental health effects of the 9/11 attacks on adults are well-documented, less is known about the impact on children and adolescents exposed to this trauma. Childhood trauma can disrupt the development of cognitive functioning, emotional regulation, and memory processing, leading to long-term effects that may emerge years later and be reflected in how the event is recalled. This research aims to use advanced technology to analyze how survivors' traumatic memories, especially those who were adolescents at the time, relate to their current mental health, with the aim to guide future mental health interventions.